STUDY OF HE ROLE OF RNASE IN VIVO IN MODULATION OF ANTISENSE ACTION

The intracellular mechanism of action of exogeneously administered antisense oligonucleotides is not known. Two mechanisms have been suggested based on studies in cell fire systems. These are: 1) inhibition of ribosome attachment or movement along MRNA; and, 2) creating a substrate for RNAse H degradation of targeted MRNA. RNAse H is an enzyme which destroys the RNA portion of an RNA/DNA hybrid complex and is present in the cytoplasm of all proliferating cells. Its natural function in cells is unknown. We have obtained a full-length CDNA coding for bacterial RNAse H. We have succeeded in constructing a mammalian episomally replicating expression vector which contains the bacterial RNAse H gene in a sense orientation. We have demonstrated by in situ gel assay that the bacterial RNAse H gene is expressed at high levels in the transfected cells and that this activity can be induced with cadmium. Cells transfected with this construct and sham-transfected cells are being compared for their responsiveness to antisense oligonucleotide addition. We are utilizing a model system which makes use of the fact that U937 cells apparently possess an autocrine growth loop regulated by IL-6. If IL-6 antisense is added to these cells, their growth is markedly inhibited. If RNAse H is involved in the intracellular functioning of antisense oligos, then cells with high levels of RNAse H should respond better to addition of these compounds.